Developmental regulation of oscillatory expression

Project Summary
Ultradian oscillatory circuits are pervasive in biological systems. These dynamic oscillators range from pulsatile
p53 expression after g-radiation, to periodic nuclear to cytoplasmic shuttling of NFkB transcription factor in
response to cytokine, to cyclic expression of Hes/Her transcription factors in stem cells and presomitic
mesoderm (PSM). Ultradian genetic oscillators are associated with patterning and developmental transitions –
oscillations correlate with yeast metabolic cycles, foreshadow periodic lateral root branching in Arabidopsis,
regulate molt cycles in larval worms, associate with stem cell pluripotency, and synchronize transcriptional
response to starvation signals in Dictostelium. One biological oscillator is the vertebrate segmentation clock,
which controls somitogenesis, the process by which the PSM is sequentially divided into segments called
somites. At the core of the segmentation clock is an auto-inhibitory negative feedback loop involving Her/Hes
transcriptional repressors, which in turn regulates oscillatory expression of additional ‘cyclic genes’. Although
the cyclic genes in human and mouse belong to similar pathways (e.g., Notch, Wnt, FGF, Yap/Hippo), genes in
those pathways which are cyclically expressed vary among species, with the Her/Hes gene family genes being
common among vertebrates. We study the zebrafish segmentation clock, which oscillates with a 30-minute
periodicity and is 4-12 times faster than in mouse or human. In order for a rapid auto-inhibitory oscillator to
operate, there must be tight control over synthesis and decay of cyclic gene transcript and protein. A recent
experiment in which the Hes7 locus was swapped between human and mouse in vitro PSM systems showed
that expression delays and decay, controlled by factors in the host cell environment, are critical regulatory
parameters of the clock. To understand the mechanisms regulating these critical parameters, we are using the
zebrafish pnrc2 mutant in which transcriptional oscillations occur normally, but post-transcriptional decay
mechanisms are disrupted, to identify additional cyclic genes and dissect their regulation. The specific aims of
the proposal are to (1) identify Pnrc2-regulated zebrafish embryonic cyclic genes that play critical
developmental roles, (2) characterize the regulatory features and factors that control rapid decay dynamics of
cyclic gene transcripts, and (3) investigate the role of other post-transcriptional mechanism in regulating
segmentation clock function. We anticipate that our work will broadly impact understanding of post-
transcriptional mechanisms regulating oscillatory expression in many developmental contexts.

Public health relevance
Project Narrative Rapid molecular oscillators are important for generating segmental pattern during development, for promoting heterogeneous responses in neural stem cells, and for biasing embryonic stem cells toward different cell fates. We propose to discover new oscillatory genes, uncover their biological functions, and dissect the regulatory mechanisms that govern their oscillatory expression. We propose that our discoveries will impact studies in fields as diverse as stem cell biology, tissue engineering, and even cancer cell biology.